Southeast Translational Alcohol and HIV Research Center (STAHR Center)

People with HIV (PWH) have a two-fold excess risk of cardiovascular disease (CVD) as compared to those
without HIV. Some of this excess risk is due to heavy alcohol consumption. Presently, few therapies exist that
effectively reduce alcohol consumption or mitigate alcohol’s harmful effects. Our overarching objective and
theme are to conduct clinical trials and observational studies that inform new clinical trials to reduce alcohol
consumption or mitigate alcohol’s harmful effects among PWH who are at risk for CVD. Informed by our prior
clinical trials and cohort studies, the Southeast Translational Alcohol and HIV Research (STAHR) Center
proposes three inter-related projects focused on alcohol, gut dysbiosis and its derived metabolites, glucagon
like peptide 1 (GLP-1), inflammation, and CVD risk among PWH. Project 1, GEM HIV, will examine the
association between alcohol, gut dysbiosis and dysbiosis derived metabolites, biomarkers of inflammation, gut
permeability, CVD risk and endogenous GLP-1 and determine whether a probiotic can increase endogenous
GLP-1 levels among PWH who are heavy drinkers. Project 2, GUT CVD HIV, will determine the association
between dysregulation of tryptophan catabolism and its metabolites (Kynurenine/Tryptophan, KYN/TRP ratio)
and alcohol, senescent T cells, vascular inflammation, and CVD and whether a probiotic can reduce the
KYN/TRP ratio, T cell senescence, and vascular inflammation among PWH who are heavy drinkers. Project 3,
GL1DER HIV RCT, proposes a randomized clinical trial that will test whether a GLP-1 receptor agonist
(semaglutide) versus placebo decreases alcohol consumption, cigarette smoking and CVD risk among PWH.
This trial will be conducted at the Tennessee Center for AIDS Research at Vanderbilt University Medical
Center (VUMC). Projects 1 and 2 will be ancillary studies to our ongoing META HIV CVD RCT (P01AA029542,
PIs Freiberg, Barve). Project 2 will also use Veterans Aging Cohort Study (VACS) data. All projects will be
supported by our Administrative (Admin) and Dissemination Cores at VUMC, and the Resource Core at
the Norton Research Institute in conjunction with the Integrated Metagenomics and Metabolomics Core at the
University of Louisville Alcohol Research Center which is part of the ongoing META HIV CVD RCT. The Admin
Core will be responsible for coordinating all study projects and cores, and the Resource Core will provide a
unified analytical platform to meet all the technical needs for the data acquisition, generation, management,
analysis, and storage needs across the three projects. The Dissemination Core will connect the STAHR
Center faculty, staff, and our research with (1) the global scientific community, (2) trainees and health care
professionals and (3) the PWH community. IMPACT: This research will advance our understanding of
alcohol’s effect on CVD among PWH. If our hypotheses are correct, endogenous GLP-1 and tryptophan
metabolites may serve as targets for future RCTs designed to reduce alcohol’s harmful effects on CVD while
GLP-1 receptor agonists may ultimately revolutionize care by reducing alcohol and CVD risk among PWH.

Public health relevance
NARRATIVE - OVERVIEW The overarching goal of the Southeast Translational and HIV Research (STAHR) Center is to conduct clinical trials and cohort studies that ultimately help people with HIV reduce alcohol consumption or reduce alcohol’s harmful effects on health. The STAHR Center consists of two studies that use the META HIV CVD RCT and VACS data to understand the role of glucagon like peptide 1 (GLP-1), a protein made by the gut, and tryptophan breakdown products as they relate to alcohol’s changes to the bacteria in the gut and cardiovascular disease among people with HIV who drink alcohol. A third study is a new randomized controlled trial designed to determine if a medicine that targets GLP-1 receptors in the body lowers alcohol consumption, cigarette smoking, and cardiovascular disease risk among people with HIV.